Explainable AI-Based Multi-Omics Analysis of Lung Cancer Health Disparity

PROJECT SUMMARY
The proposed research aims to understand and discover the disparity of lung cancer development between
African Americans and European Americans, considering race and sex. For example, Among American Males,
the highest number of deaths occur from lung cancer, which is more deaths than kidney, pancreas, and prostate
cancers combined. African American Males have significantly higher death rates in lung cancer compared to
European American Males. Cigarette smoking is considered the strongest risk factor for lung cancer. However,
smoking alone cannot explain the disparity in lung cancer development between African American Males and
European American Males. The traditional cohort-based genome-wide association studies failed to identify the
African American Male-specific genetic locations susceptible to causing lung cancer. These studies are similar
to the current standard of medical practice, which largely relies on population-based epidemiological studies in
which individuals' genetic and epigenetic variabilities are largely ignored, resulting in population-based
conclusions. As a result, similar cancer types respond differently to the same treatment since each tumor has a
unique set of mutations. A personalized approach that can identify the patient-specific genetic and epigenetic
alterations leading to the disparities in lung cancer incidence and mortality may overcome the issues with
population-based studies.
Recent advancement in explainable artificial intelligence shows that by applying the local interpretation based
on game theory, one can discover the patient-specific significant genes related to a disease condition by
analyzing the gene expression profile of a patient. We propose to develop an explainable artificial intelligence-
based computational tool to explore multi-omics data in deciphering the lung cancer health disparity by
discovering, first, patient-specific disparity information, second, cohort-specific disparity information combining
individual disparity information, and third, disparity between two cohorts by comparing cohort-specific disparity
information, which will lead to the discovery of cohort-specific risk factors. The proposed tool can be applied to
find the cohort-specific risk factors by creating and comparing cohorts based on race and sex, such as African
American Males vs. European American Males, African American Females vs. European American Females,
etc. Thus, the developed tool will help solve the disparity puzzle that exists in lung cancer incidence and mortality
in different races and ethnicities. The proposed work is important since it will identify the heterogeneity of lung
cancer at a personalized level, which may help precision medicine's rational design. This improved precision
medicine design will help reduce lung cancer health disparities between different ethnic and racial communities
and maximize the therapeutic benefit in all communities.

Public health relevance
Project Narrative The proposed research aims to understand and discover the biological factors of health disparities in lung cancer between African Americans and European Americans at the multi-omics level. An explainable artificial intelligence-based computational framework will be developed using a cooperative game theory-based machine learning approach, first, to identify patient-specific tumor heterogeneity or disparity information, second, to identify cohort-specific disparity information, and third, to discover disparity between two cohorts. The developed tool will help decipher the race- and sex-specific risk factors such as African American Males, European American Males, African American Females, European American Females, etc., which will guide better treatment strategy, thus, benefitting humanity.